Administrative and Research Translation Core

Administrative & Research Translation Core ABSTRACT
The Administrative and Research Translation Core is the central hub for all activities of the Texas
A&M University Superfund Research Center. It is organized around three key functions that will
enable it to be an effective and nimble coordinator of the proposed research, outreach, training,
and translation activities: (1) administration and fiscal management, (2) integration of crossdisciplinary
disaster response research (DR2), and (3) outreach and research translation. This Core
is physically located in the Department of Veterinary Integrative Biosciences at Texas A&M
University in College Station, TX. The Core operates through regular Center-wide and projectspecific
meetings, tracks the productivity of the Center, develops future activities, and guides
scientific innovation through a pilot project program. The Core is led by Center Director (Ivan
Rusyn) and Associate Director (Weihsueh Chiu), and includes an administrative manager and a
fiscal manager. The Core is coordinating Center leadership and activities with two committees. The
PIs of the projects and cores in the Center form a Scientific Steering Committee, which meets
monthly. External oversight of the Center is the responsibility of an External Advisory Committee,
which meets annually to perform program evaluation of the Center and determine whether
research, outreach, training, and translation goals and objectives are being met. This Committee
is a multi-disciplinary group of highly qualified experts representing academia, federal and state
governmental agencies, industry, and non-governmental organizations. The Core’s work is
organized around five Specific Aims. First, the Core provides effective administrative and fiscal
management with input from the Scientific Steering and External Advisory Committees. The Core
conducts program planning and evaluation and assessment of Center performance. Second, the
Core enables integration of cross-disciplinary DR2 research through monthly meetings, annual
retreats, and internal/external collaborations. The Core issues annual calls for pilot projects,
coordinates their review and oversees deliverables from each pilot project. Third, the Core
promotes dissemination of the Center’s outputs to NIEHS and other stakeholders. Fourth, the Core
maintains and expands partnerships with government (local/state/Federal) agencies, nongovernmental
organizations (NGOs) and community partners. It will continue holding regular
meetings with the end-users to showcase Center’s work and conduct demonstration workshops.
Finally, the Core is advancing the practical application of Center DR2 research through technology
transfer. All Center faculty, staff and trainees will interact with the Core as it executes its
administrative (overall and fiscal management, integration) and research translation
(communication, outreach, technology transfer) functions.

Public health relevance
Administrative & Research Translation Core NARRATIVE The Administrative & Research Translation Core is providing leadership and guidance to the Texas A&M University Superfund Research Center. It provides general Center management support, promotes cross-discipline interactions among all projects and cores, and facilitates research translation. The Core operates through regular Center-wide and project-specific meetings, tracks the productivity of the Center, develops future activities, and guides scientific innovation through a pilot project program. The Core also coordinates the Center’s disaster research response (DR2) activities, training, community engagement and outreach with input from two advisory committees.